Control of Type I Interferon Production in Response to Candida albicans

PROJECT SUMMARY
Invasive fungal infections represent a major threat to immunocompromised patients and despite the availability of anti-
fungal antibiotics, mortality rates remain as high as 50%. Candida spp. is fifth among hospital-acquired pathogens and
fourth among bloodstream infections. Human SNPs in the type I interferon (IFN) pathway have been associated with
increased susceptibility to candidemia. While these data suggest a significant role of type I IFNs in C. albicans host defense,
the signaling pathway that licenses type I IFN production and regulation during C. albicans infection remains elusive.
Although small in numbers, plasmacytoid dendritic cells (pDCs) are the primary producers of type I IFNs (IFNα and IFNβ)
in response to viral and bacterial pathogens though other cells (i.e. macrophages and monocytes) contribute to type I IFN
production as well. Upon activation, toll-like receptors (TLRs) 7 and 9 can upregulate type I IFN production or
chemokine/cytokine production via IRF-7 and NF-κB pathways, respectively. Although induction of type I IFNs are well
described in response to viral and bacterial pathogens, a crucial knowledge gap remains with respect to the mechanisms by
which this pathway affects fungal pathogenesis. We have made several key observations to define the role of type I IFNs in
response to C. albicans. We show that pDCs from mice infected with C. albicans intravenously significantly upregulate the
activation markers, CD40 and CD86, as compared to uninfected mice. TLR9 and Dectin-1 are required for IFNα/β
production. TLR9 trafficking to fungal endosomes require Dectin-1 and Syk signaling. Furthermore, a microarray analysis
of wild-type and TLR9-knockout macrophages revealed IFN inducible family genes (IFI203, Mnda, and Ifi1) as dependent
on TLR9, implicating its role in the regulation of IFN signaling. Type I IFNs improve killing capacity of neutrophils in
response to C. albicans. We additionally demonstrated that in the absence of critical IFN signaling components (i.e. STING,
cGAS, IRF-3, and IFN receptor) mice demonstrate striking resistance to candidemia, but at the cost of a higher fungal
burden. These exciting data suggest that dysregulation of IFN signaling significantly affects the outcomes of invasive
Candida infections. Lastly, our preliminary studies implicate a role for STING in the production of the negative feedback
regulator SOCS1 (suppressor of cytokine signaling). Thus, our long-term goal is to understand the regulation and role of
type I IFNs in host defense against invasive candidiasis. To address our long-term goal, we propose the following three
aims: (1) elucidate the signaling pathway for TLR9-dependent type I IFN production in response to C. albicans, (2)
determine the impact of cGAS, STING, and IRF-3 in the host defense against candidemia, and (3) identify the mechanism
of C. albicans-induced SOCS1 to block TLR9-dependent type I IFN production. This work will provide greater
understanding of type I IFN response to invasive candidiasis and may lead to novel therapeutic targets to modulate the
immune response to alter clinical outcomes in candidemic patients.

Public health relevance
PROJECT NARRATIVE Invasive fungal infections are some of the most dreaded infections for immunocompromised patients. This application seeks to understand how type I interferons, important molecules in the innate immune system, control the outcome of fungal infections.